Gut Microbiome and Individual Differences in Lumbosacral Radicular Pain

The profile of pain severity, impact, and persistence after (surgical) treatment is heterogeneous. For example,
some patients with lumbosacral radicular pain, who do not respond to conservative therapies, eventually undergo
spine surgeries. While many improve after surgery, some continue to suffer from back or leg pain, or develop
new or worsened symptoms, leading to unfavorable outcomes. While the mechanisms underlying individual
differences in pain including lumbosacral radicular pain are unknown, a large body of evidence suggests that
genetic factors appear to explain only a small fraction of the individual variability in pain outcomes, suggesting
significant contribution from other factors. The gut microbiome is a critical player in hosts’ physiology. Recently,
important links between the gut microbiome and chronic pain have been elucidated, raising the question of
whether the gut microbiome contributes mechanistically to the individual differences in lumbosacral radicular
pain. In previous studies, we have established critical roles of the gut microbiome in neuropathic pain. More
recently, we conducted a metabolomics study in patients undergoing hip, knee and spine surgeries and found
that blood levels of 3-aminoisobutyric acid were negatively correlated with pain control. Notably, 3-
aminoisobutyric acid has been linked to PGC-1α, a key molecule modulating pain processing. Besides extensive
experiences with -omics in pain, this investigator team has built a cutting-edge tool for functional assessment of
pain aided by artificial intelligence. Leveraging machine learning algorithms, we have established a robust and
reliable pipeline that can accurately identify and quantify a diverse set of real-life activities. This tool will be
implemented to capture the global impact of pain and the progress of pain relief in free-living conditions. Built on
existing data and our own research, we hypothesize that the gut microbiome is a mediator of inter-individual
differences of lumbosacral radicular pain with or without back pain (LSRP), including its responsiveness to spinal
surgery. We plan to recruit 250 LSRP patients (150 for Aim1&2; 100 for Aim 3) who undergo spine surgery and
carry out three Aims: Aim 1: To deeply phenotype LSRP using shot-gun metagenomics, metabolomics, real-life
activity based functional assessment, sleep and psychosocial questionnaires. Aim 2: To interrogate if the gut
microbiome mediates the individual differences in LSRP. For this, we will follow up patients up to 12 months post
spine surgery and determine their pain outcomes. Aim 3: To establish a model that integrates the microbiome,
metabolome, and psychosocial features for LSRP inter-personal differences including its responsiveness to
spine surgery. Additionally, we will enroll another cohort (100 patients) with LSRP who are scheduled for spine
surgery with 12 months follow up postoperatively. This additional cohort will validate and refine the model to
characterize inter-personal differences in pain. A successful execution of proposed studies will provide novel
mechanistic understanding of individual differences in LSRP, facilitate patient stratification for spine surgery, and
inform the development of evidence-based treatment towards precision and personalized pain medicine.

Public health relevance
In response to RFA-NS-24-021, the goal of this project is to dissect the biological underpinnings of individual differences in LSRP, focusing on modifiable factors, such as the gut microbiome and its metabolites. Leveraging metagenomics, metabolomics, machine-learning based real-life functional assessment and robust data analytic pipelines, this proposal will provide novel mechanistic understanding of individual differences in LSRP, facilitate patient stratification for spine surgery, and inform the development of evidence-based treatment towards precision and personalized pain medicine.